EFFECTS OF TOBACCO SMOKE ON PRIMATE SPERM FUNCTION AND GENETICS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The objective of this project is to determine the effects of environmental tobacco smoke on male reproductive function.